Core Grant for Vision Research-LABORATORY COMPUTER APPLICATIONS MODULE (LCAM)

Laboratory Computer Applications Project Summary/Abstract
The Laboratory Computer Applications Module (LCAM) provides support to individual and collaborative
efforts by providing training in the advanced use of scientific software as well as research programming and
consulting services for research projects. Furthermore, it supports all other core modules (Animal Resource,
Flow Cytometry and Morphology) by managing the gathering, processing, and analyzing data on the
various computerized systems at each module. The LCAM provides the expertise to facilitate real-time
data transfers, convert image-based data to analytic forms, to update and purchase new and additional
software, interconnect microcomputer systems between laboratories and equipment, to provide
programming resources for such interfaces, and to facilitate analyses within laboratories. Finally, the LCAM
supports the application and integration of machine learning algorithms for advanced imaging data analysis by
providing a hardware and software infrastructure and the necessary training and consulting.